Biostatistics and Informatics Core

BIOSTATISTICS AND BIOINFORMATICS CORE: PROJECT SUMMARY
The overall objective of the TRACER Biostatistics and Bioinformatics Core (BBC) is to serve as the focal point
from which the TRACER investigators and career development candidates can draw the much needed
biostatistical, genomics, and biomedical informatics expertise needed for proper planning and execution of their
research projects. These services include assisting in experimental design, study plan development, hypotheses
refinement, database integration and access, data quality control, sample size requirements and power
calculations, analysis of the statistical design, development of randomization and stratification procedures,
interim analyses, analysis of completed results (which includes both biostatistical and genomics analyses),
presentation of research findings, and scientific publication to disseminate new findings in the prevention and
treatment of lung cancer. The BBC resource will be directed by Dr. Bandyopadhyay from VCU, with core
personnel included across the three TRACER sites. To materialize the TRACER objectives, the BBC has
proposed 3 specific aims, which broadly encompasses providing biostatistical and genomics analytics expertise
(Aim 1), providing efficient data management, integration and distribution (Aim 2), and provide the much needed
biostatistical training to TRACER investigators and community partners, as well as exploring novel
advancements in biostatistical methodology in lung cancer (Aim 3). To achieve this, BBC personnel, in addition
to their own research interactions with the TRACER members, can also call on additional assistance from various
other biostatisticians, bioinformaticians, genomics experts, and senior statistical analysts with significant cancer
expertise, all integrated within the respective Biostatistics Shared Resources at the NCI-designated cancer
centers at VCU, MUSC, and CoH. The BBC thus constitute a tightly integrated component of the TRACER, and
the services provided will add significant value to the realization of TRACER goals, which would not have been
achieved through alternative vendors.

Public health relevance
BIOSTATISTICS AND BIOINFORMATICS CORE: PROJECT NARRATIVE The Biostatistics and Bioinformatics Core (BBC) will serve as a tightly integrated component of the TRACER, providing the much needed biostatistical, genomics, and biomedical informatics expertise desired by the TRACER investigators. The services thus provided by BBC will add significant value to the realization of the TRACER goals, and in the longer term, will advance the TRACER team towards a successful P50 application.